Computational Core

Project summary
The aim of Core B is to provide an adequately detailed biophysical model of thalamocortical interactions to allow
the model to guide experiments of the Thalamus Conte Center, especially Projects P1-P3. The Center is
proposing to understand the function of higher-order thalamus in tasks involving attention and decision making,
particularly when there are uncertainties in sensory input or context. The Center hypothesis is that higher-order
thalamic nuclei in the primate brain, particularly the mediodorsal nucleus (MD) and the pulvinar (PUL), play a
fundamental role in integrating and gating cortical activity and coordinating information flow across large-scale
cortical networks. Indeed, we propose that an understanding of the functioning of cortical cognitive networks in
the primate brain is not possible without understanding the interactions of cortex and thalamus. The experiments
to be done in P1-P3 involve non-human primates and tree shrews in a way that will constrain circuit models of
both dynamics and function. In addition, the group will also investigate animal models of schizophrenia (SZ)
(P3). In both the normal and SZ animal models, the experimentalist will gather information about brain rhythms
and spike timing need for the model. Our model will also be informed by network data from healthy humans (P4)
and Schizophrenia patients (P5). The computational model to be constructed in core B will use the detailed
physiological framework of Hodgkin-Huxley equations, constrained by currently available and future data. The
model will be built with multiple modules, each with multiple cell types, each producing multiple kinds of dynamics
that can themselves change rhythmically on a slow time scale. Each of these modules can change with effects
of neuromodulation, and the functional connections among them are also subject to modulation. Such a complex
model needs to be highly constrained, and we will make use of a novel methodology in which each module is
constrained by known physiology plus the multiple dynamical behaviors that it must produce with different inputs.
The anatomy of the model is partly motivated by earlier work with Kastner explaining the roles of multiple brain
rhythms in a spatial attention task and showing that those frequencies are functionally important. Indeed, the
current work, in which the tasks require us to consider similarly complex interactions, raises the very general and
important question: Is such biological complexity important for function, and in what ways? We hypothesize that
the known complex rhythms are essential to function; in the proposed work of Core B, we aim to spell out in what
ways those dynamics are important in the context of tasks requiring attention, decision making and rule changing.
In Aim 1, we investigate the effects of cortical dynamics on pulvinar and MD. In Aim 2, we consider the changes
in dynamics when there is uncertainty about which is the cue and there is switching in the rule. In Aim3, in the
context of schizophrenia, we consider how dysfunctions in thalamic rhythms and in inhibitory function can lead
to cognitive deficits, using the work of Aims 1 and 2. This work is expected to contribute to answers to the
question of why the higher order thalamus is needed for cognition.